ELAV-mediated trafficking and synaptic C/EBP mRNA localization in long-term memory formation

1 PROJECT SUMMARY
2
3 Long-term memory (LTM) formation is a critical process for the survival of virtually all animals. The
4 ability to acquire, store, and recall information over long periods of time is crucial for even the most basic
5 aspects of life including feeding, defense, mating, as well as more advanced social behaviors. Even more
6 striking is that the cellular and molecular mechanisms underlying LTM formation are remarkably evolutionarily
7 conserved and are shared in some part by every creature on earth. Understanding the infinitely complex
8 choreography of cells and molecules that gives rise to LTM formation is made possible by the study of simple
9 neural systems, such as the central nervous system of the marine mollusk Aplysia californica. In this system,
10 presynaptic facilitation of the sensory neuron – motor neuron (SN-MN) circuit in the pleural-pedal ganglia
11 completely mediates behavioral LTM for sensitization of the animal’s defensive tail-elicited tail withdrawal
12 reflex. Using this system, our laboratory has previously demonstrated that members of a specific family of
13 RNA-binding proteins (ELAVs) are required for the stabilization of apc/ebp mRNA, and this stabilization is
14 required for LTM formation in Aplysia. We have recently discovered that ELAVs shuttle from the SN nucleus to
15 distal neurites and synapses after LTM training, and that the ELAV target mRNA apc/ebp is present in distal
16 SN neurites after training. Since ELAVs bind a large quantity of RNAs, a change in the binding profile of ELAVs
17 by LTM training can have profound effects on the cellular transcriptome including transcript stabilization,
18 alternative splicing, and mRNA shuttling. In fact, differential regulation of ELAV binding has been shown to
19 affect amyloid processing and alternative pre-mRNA splicing in brains of Alzheimer’s Disease patients. In Aim
20 1, I propose a research program to identify the differential RNA binding profile of ELAVs in the SNs of Aplysia
21 resulting from LTM training. I will use the experimentally advantageous organization of the Aplysia nervous
22 system to complete targeted dissections of the SN neurites and determine which of these ELAV target RNAs
23 are shuttled towards the SN-MN synapse during LTM formation. In Aim 2, I will investigate the mode of
24 trafficking and the functional consequence of apc/ebp mRNA at distal SN neurites. Noting the binding of
25 apc/ebp mRNA by ELAVs during LTM formation, I predict that ELAVs are required for distal apc/ebp mRNA
26 localization. I hypothesize that this localization underlies a mechanism for ‘savings’ memory, the reinstatement
27 of a latent, non-expressed memory trace by a later reminder event. The experiments outlined in this proposal
28 will serve to produce data strategically useful for the development of novel drugs and therapies for neurological
29 disorders, as well as to further our understanding of how these molecular mechanisms support the brain’s
30 remarkable capacity for synaptic plasticity.

Public health relevance
PROJECT NARRATIVE Long-term memory formation is a critical survival process for virtually all animals that requires coordinated molecular signaling; the disruption of this signaling underlies deficits in learning, especially in neurological disorders. The successful induction of long-term memory requires lasting changes to cellular and synaptic physiology, which are in large part brought about by post-transcriptional regulation of the cellular transcriptome on the levels of both transcript abundance and subcellular localization. This research program will investigate the contribution of specific members of a class of RNA-binding proteins (ELAVs) towards long- term memory formation by (i) identifying their RNA targets, (ii) examining their ability to target RNAs to distal sites and synapses, and (iii) interrogating the functional consequences of this trafficking in learning.